Washington University Institute of Clinical and Translational Sciences (KL2)

Contact PD/PI: Powderly, William G. Inst-Career-Dev-001 (463)
I. Institutional Career Development Core (KL2), 7. Project Summary/Abstract:
The goal of the Washington University (WU) KL2 Career Development Program is to provide team-oriented,
competency-based, multidisciplinary mentored research training, didactic coursework, and professional
development for junior faculty. Our Clinical ResearchTraining Center (CRTC) provides educational resources
and infrastructure for the WU Institute of Clinical and Translational Science (ICTS) and partner institutions.
We are requesting 9 KL2 slots to support junior faculty for 2-3 years. To enhance our successful KL2, we will
develop additional innovative coursework, training and career development programs across the full
spectrum of T1-T4 research, emphasizing informatics and data science, health equity and implementation for
impact. To address the regional and national CTSA goals, we propose the following specific aims:
1: Enhance the CRTC and KL2 infrastructure and programs to provide personalized, competency-
based, rigorous, high-impact clinical/translational research training and skills. We will develop and
provide new curricula and training programs emphasizing implementation science for impact and equity. We
will enhance our hybrid and online courses to improve access and flexibility for trainees and share materials
with ICTS partners and other CTSA hubs. (CTSA Goal:Translational Workforce Development)
2: Provide high-quality, informatics training. We will enhance our informatics and data science training
(workshops, seminars, courses, certificates, and degrees), and integrate new informatics methods, tools and
skills into our courses and training programs to meet individual scholar needs. (CTSA Goal: Informatics)
3: Expand the number and diversity of investigators leading high-impact, multidisciplinary,
clinical/translational research teams. We will train scholars, faculty and mentors from diverse disciplines and
promote recruitment and retention of faculty and scholars from under-represented in medicine (URiM) groups.
To expand high-impact research in diverse communities and populations across the lifespan, we will integrate
new team-science, URiM focused mentoring and leadership development into our courses and career
development programs (CTSA Goals: Integrating Special Populations across the Lifespan)
4: Increase collaborations between the faculty, mentors, and scholars in the KL2 program and
stakeholders, ICTS program functions, partners, and CTSA hubs. We will create new resources, share
best practices, and advance diverse interdisciplinary scientific teams to foster patient and community engaged
research and training at local, regional, and national levels. (CTSA Goal: Collaboration and Engagement)
5: Demonstrate the impact of the KL2 program. We will assess the short- and long-term performance of
scholars, determine the efficacy of training methods, and use this data to improve training, trainee and faculty
satisfaction, mentoring, diversity, leadership and outcomes. (CTSA Goal: Methods and Processes)
Project Summary/Abstract Page 1137
Contact PD/PI: Powderly, William G. Inst-Career-Dev-001 (463)
I. Institutional Career Development Core: KL2 Component
9. Bibliography and References Cited
1. Tsevat J, Smyth SS. Training the translational workforce: Expanding beyond translational research to
include translational science. J Clin Transl Sci. 2020 Apr 6;4(4):360-362. PMCID: PMC7681113.
2. Sorkness CA, Scholl L, Fair AM, Umans JG. KL2 mentored career development programs at clinical and
translational science award hubs: Practices and outcomes. J Clin Transl Sci. 2020 Feb;4(1):43-52. PMCID:
PMC7103475.
3. Robinson GF, Schwartz LS, DiMeglio LA, Ahluwalia JS, Gabrilove JL. Understanding Career Success and
Its Contributing Factors for Clinical and Translational Investigators. Acad Med. 2016 Apr;91(4):570-82. PMCID:
PMC4811729.
4. Guerrero LR, Nakazono T, Davidson PL. NIH Career Development Awards in Clinical and Translational
Science Award institutions: distinguishing characteristics of top performing sites. Clin Transl Sci. 2014
Dec;7(6):470-5. PMCID: PMC4361077.
5. Scozzi D, Cano M, Ma L, Zhou D, Zhu JH, O'Halloran JA, Goss C, Rauseo AM, Liu Z, Sahu SK, Peritore V,
Rocco M, Ricci A, Amodeo R, Aimati L, Ibrahim M, Hachem R, Kreisel D, Mudd PA, Kulkarni HS, Gelman AE.
Circulating mitochondrial DNA is an early indicator of severe illness and mortality from COVID-19. JCI Insight.
2021 Feb 22;6(4). PMCID: PMC7934921.
6. Mody A, Pfeifauf K, Geng EH. Using Lorenz Curves to Measure Racial Inequities in COVID-19 Testing.
JAMA Netw Open. 2021 Jan 4;4(1):e2032696. PMCID: PMC7794664.
7. Mody A, Lyons PG, Guillamet CV, Michelson A, Yu S, Namwase AS, Sinha P, Powderly WG, Woeltje K,
Geng EH. The Clinical Course of COVID-19 Disease in a US Hospital System: a Multi-state Analysis. Am J
Epidemiol. 2020 Dec 22. PMCID: PMC7799307.
8. Mody A, Pfeifauf K, Bradley C, Fox B, Hlatshwayo MG, Ross W, Sanders-Thompson V, Joynt K, Reidhead
M, Schootman M, Powderly WG, Geng EH. Understanding Drivers of COVID-19 Racial Disparities: A
Population-Level Analysis of COVID-19 Testing among Black and White Populations. Clin Infect Dis. 2020 Dec
14. PMCID: PMC7799327.
9. https://crtc.wustl.edu/resources/otg.
10. https://icts.wustl.edu/research-services/research-development-program/.
11. Sweeney C, Schwartz LS, Toto R, Merchant C, Fair AS, Gabrilove JL. Transition to Independence:
Characteristics and Outcomes of Mentored Career Development (KL2) Scholars at Clinical and Translational
Science Award Institutions. Acad Med. 2017 Apr;92(4):556-562. PMCID: PMC5373479.
12. Abedin Z, Biskup E, Silet K, Garbutt JM, Kroenke K, Feldman MD, McGee R, Jr., Fleming M, Pincus HA.
Deriving competencies for mentors of clinical and translational scholars. Clin Transl Sci. 2012 Jun;5(3):273-80.
PMCID: PMC3476465.
13. Keyser DJ, Lakoski JM, Lara-Cinisomo S, Schultz DJ, Williams VL, Zellers DF, Pincus HA. Advancing
institutional efforts to support research mentorship: a conceptual framework and self-assessment tool. Acad
Med. 2008 Mar;83(3):217-25.
14. https://cimerproject.org/entering-mentoring/
15. Meagher E, Taylor L, Probsfield J, Fleming M. Evaluating research mentors working in the area of clinical
translational science: a review of the literature. Clin Transl Sci. 2011 Oct;4(5):353-8. PMCID: PMC3727275.
16. Nearing KA, Nuechterlein BM, Tan S, Zerzan JT, Libby AM, Austin GL. Training Mentor-Mentee Pairs to
Build a Robust Culture for Mentorship and a Pipeline of Clinical and Translational Researchers: The Colorado
Mentoring Training Program. Acad Med. 2020 May;95(5):730-736. PMCID: PMC7644265.
17. https://crtc.wustl.edu/wp-content/uploads/CRTC_Teaching-with-Technology-Manual.pdf
18. https://www.ahrq.gov/teamstepps/master-training-course.html.
19. Byington CL, Keenan H, Phillips JD, Childs R, Wachs E, Berzins MA, Clark K, Torres MK, Abramson J, Lee
V, Clark EB. A Matrix Mentoring Model That Effectively Supports Clinical and Translational Scientists and
References Cited Page 1138